GeneMatcher, VariantMatcher and PhenoDB, implementation of new features and connections

Project Summary/Abstract
The interpretation of thousands to millions of variants identified in whole exome and genome sequencing
(WES/WGS), respectively, is a challenging task and requires variant frequency together with phenotype
information that are not available in most public databases. The development of tools that enable data sharing
of genomic data together with phenotypic features is essential for rare disease gene discovery. In 2013 we
created GeneMatcher (10,574 users in 93 countries, cited in >380 publications), the first and most used web-
based tool to connect individuals (researchers, clinicians, patients, etc) around the globe with interest in the
same genes, variants or phenotypes. In 2019, we developed VariantMatcher (625 users in 43 countries, 428
queried variants, 61 matched variants), to share variant-level and phenotypic data from WES/WGS. To enable
variant prioritization for investigators around the world, we developed PhenoDB (> 143 unique downloads of
source code, 1,828 users from 65 countries). This freely available, web-based tool allows users naïve to
bioinformatics to store, share, analyze and interpret patient phenotypes and sequence variants from WES/WGS.
Users currently store in one instance of PhenoDB extensive phenotypic data (described with 3,646 terms
mapped to HPO) from 37,712 individuals in 9,711 families with an average of 6.8 features/affected individual,
describing > 2,282 diseases. Annotated WES/WGS variants are available for 7,724 individuals from 4,446
families. PhenoDB facilitates data sharing and analysis access world-wide. As of 1 December 2020, 6,151
sequenced individuals in PhenoDB were consented and submitted for phenotypic and genotypic matching
through VariantMatcher. However, the ongoing development of new sequencing methods, analysis pipelines
and data sharing platforms requires development of novel functions in our highly utilized resources and
integration with other newly created platforms to ensure that thousands of investigators can perform state of the
art analysis of genomic and phenotypic data to better interpret candidate variants. There is a critical need to
maintain and improve tools that allow genomic and phenotypic data integration and sharing. To fill this need, we
will leverage input from users of PhenoDB, GeneMatcher and VariantMatcher, collaborations with creators of
tools and platforms with complementary functions, and our evolving expertise in sequencing analysis and gene
discovery to improve our community resources. To this end, we will:
1. Implement new functions in GeneMatcher, VariantMatcher and PhenoDB to enable additional types of
queries, variant filtering and prioritization pipelines.
2. Connect GeneMatcher and VariantMatcher with other, community-wide data sharing tools and
integrate PhenoDB with other workflow platforms.
3. Expand our PhenoDB Genomic Education program.

Public health relevance
Project Narrative Only ~22% of the human protein coding genes have been found to have a phenotype‐causing variant, the molecular basis of at least 3,298 phenotypes is not known, and many more Mendelian phenotypes have not yet been described. These data together with the fact that the vast majority of the disease‐causing variants investigated up to now are single‐nucleotide variants in the coding region suggests that there is a long way to go if we are to identify the molecular basis of every Mendelian phenotype, the details of the phenotypes, and the origins of the associated phenotypic variability (Sobreira and Valle, 2016). Enhancing genomic and phenotypic data sharing including better partnership with the patients will be fundamental to the discovery of the disease genes, the understanding of the diseases' mechanisms and development of treatments; since, this project focused on genomic and phenotypic data sharing will have broadly beneficial consequences for genetics and medicine.